CRH dysregulation of brainstem autonomic circuits increases SUDEP risk

PROJECT SUMMARY
This Diversity Supplement will support Emanuel Coleman to further his technical and career development
training to prepare to apply for a Ph.D. program in Neuroscience. Building on his previous research experience
investigating the behavioral sequelae of early life stress and his interest in neurological disorders, he will conduct
research related, but not overlapping with the parent grant which seeks to investigate the impact of chronic stress
on epilepsy outcomes. Manny’s project will investigate the impact of early life stress on epilepsy outcomes,
strengthening the overall goals of the parent application while providing Manny with an independent research
experience and career development training. This project will also examine whether early life stress alters the
frequency of spontaneous recurrent seizures in the intrahippocampal kainate model of chronic epilepsy. He will
evaluate whether early life stress increases vulnerability to psychiatric comorbities in epilepsy and/or SUDEP
risk. He will gain training in in vivo electrophysiological methods, surgical techniques, and behavioral
assessments. In addition, he will participate in lab meetings, journal clubs, Departmental seminars, and
participate in career development training alongside the Building Diversity in Biomedical Sciences program. In
addition, the parent grant involves a collaboration with Dr. Carie Boychuk’s lab at UTHSA. Under this Diversity
Supplement, Manny will have the opportunity to visit Dr. Boychuk’s lab and gain knowledge regarding the
regulation of the autonomic nervous system and the impact of stress on this system (see letter attached). This
is a technically feasible and conceptually innovative project which will expand Manny’s technical skills and
prepare him for the next steps in his graduate career.

Public health relevance
PROJECT NARRATIVE This Diversity Supplement aims to provide Emanuel Coleman, who meets the NIH diversity candidate criteria, a post-Baccalaureate research and career development training opportunity. Manny will conduct a parallel, but non-overlapping project related to the parent grant, investigating the impact of early life stress on epilepsy outcomes, including the impact on seizure frequency, psychiatric comorbidities and SUDEP risk. In addition to his research training, Manny will participate in extensive career development training to prepare him for the next steps in his career path – applying to Ph.D. programs in Neuroscience.